High-throughput Spheroid Bioprinting Technology for Scalable Fabrication of Tissues

ROJECT SUMMARY/ABSTRACT
The ability to bioprint cellular aggregates, such as spheroids, in a high-throughput manner into desired patterns
or cellular microenvironments is crucial to facilitate fabrication of scalable constructs with cell densities similar to
that of native tissues and organs. Despite the progress in spheroid bioprinting technologies, the major
shortcomings associated with them, such as poor positioning of spheroids, significant loss of viability and
structural integrity, poor repeatability of the process when using non-uniform size spheroids, inability to form
complex 3D shapes, and most importantly, the lack of scalability, limit their translation. In this project, we propose
a highly unique technology, henceforth referred as “high-throughput spheroid (HTS) bioprinting,” that enables
simultaneous bioprinting of several spheroids with an order of magnitude size range and minimal cellular
damage, at a high positional precision and an unprecedented speed. The proposed technology is highly versatile
and enables the bioprinting of complex structures either (1) onto the surface of gel substrates (i.e., hydrogels) in
a scaffold-based manner or (2) within support baths (i.e., sacrificial microgels) in a scaffold-free manner for
scalable fabrication of tissues. In Specific Aim 1, we propose to develop HTS bioprinting, which has the capability
of depositing several spheroids simultaneously on 3D gel substrates, thus bioprinting a complete layer of the 3D
tissue at once in a rapid fashion (i.e., 100 spheroids can be bioprinted in <20 sec). We will couple HTS bioprinting
with extrusion-based bioprinting of gel substrates and explore the spheroid-gel interactions, across a wide range
of hydrogels, during the bioprinting process. To exemplify the technology, we will demonstrate bioprinting
intraoperatively via depositing osteogenically-committed bone spheroids for the repair of craniomaxillofacial
bone defects in a rat model. In Specific Aim 2, we will reconfigure the HTS bioprinting technology for freeform
positioning of spheroids within sacrificial support baths. Here, we will bioprint spheroids sequentially (one after
the other) in a rapid manner and pattern them according to the target design. We will explore the gel-spheroid-
bioprinting process interactions, where the effectiveness of the technology will be tested for multiple support
baths, including alginate microgels to be fabricated using the air-jet assisted coaxial flow technique along with a
commercially available benchmark. We will exemplify the utilization of the technology for fabrication of
anatomically-relevant complex-shaped human bronchopulmonary segments. In this regard, we have formed a
complementary collaboration that merges essential domain knowledge in bioprinting, bioprinting process and
instrument development, biomaterials, craniofacial surgery, and bone and lung tissue engineering with the depth
necessary to propel the proposed work towards meaningful advances that would otherwise not be possible.
Successful completion of the proposed work is anticipated to give rise to an advanced bioprinting technology for
HTS bioprinting and thereby provide a novel tool for fabrication of scalable tissues and organs.

Public health relevance
PROJECT NARRATIVE The proposed work will demonstrate a new bioprinting technique enabling high-throughput positioning of tissue spheroids in a precise manner in three dimensions (3D) and explore the use of such a technique for fabrication of bone tissue and bronchopulmonary segments. Successful completion of the proposed work will have a great potential to pioneer the development of disruptive high-throughput bioprinting technologies and advance their utilization in fabrication of organ substitutes.